Efficient Measurement and Characterization of Genetic Interactions in Cancer Cells

The concept of synthetic lethality holds great promise in cancer targeting, as a critical
principle for conceptualizing how to effectively target tumors with combinatorial therapies.
However, the vastness of the pairwise gene search space demands integration of advanced
computational and experimental approaches. The complete map of genetic interactions in yeast
has yielded insight into the functional organization of the eukaryotic cell and extending this
approach into mammalian cells promises to both elucidate the “wiring diagram” of a normal cell
and reveal how that network is rewired in cancers and in genetic diseases more broadly.
CRISPR technologies have made genetic screens in mammalian cells tractable but, to date,
even CRISPR-mediated genetic interaction assays do not scale effectively due to the inherent
combinatorial nature of a gene-vs-gene search space. Moreover, the necessity of measuring
interactions in different cell types renders the task at least two orders of magnitude larger in
human cells than in yeast. To realize the potential of synthetic lethal interactions in cancer, the
field requires major improvements in both assay efficiency and in predictive models that narrow
the search space.
We have developed a CRISPR/Cas12a based multiplexing system called IN4MER that
accurately quantitates genetic interactions with five-fold fewer reagents than the current state of
the art. In parallel, we reverse engineer the yeast functional interaction network to predict
regions of the search space enriched for genetic interactions and apply these findings to human
data to guide experimental design. We hypothesize that, by integrating our computational and
experimental approaches, will identify biologically relevant functional modules that are enriched
for genetic interactions. With our highly efficient IN4MER platform, we can assay all pairwise
combinations of hundreds of target genes at a scale comparable to a standard genome-wide
monogenic knockout screen. By doing so across dozens of relevant cell lines, we can
understand how genetic interaction networks vary across lineage and mutation state, identifying
candidate synthetic lethalities for tumor-specific therapeutic exploitation. Further, screening data
will feed back into the predictive model, iteratively increasing the efficiency and discovery
potential of this approach. This proposal offers the potential for a major advance in
understanding the basic biology implications of genetic interactions and the translational
opportunities for exploiting context-specific synthetic lethalities in cancer and beyond.

Public health relevance
Project Narrative Genetic interactions govern the emergence of phenotype from genotype at every level, but our capacity to probe and decipher these interactions is severely limited. We propose a hybrid computational and experimental effort to discover genetic interactions in cancer cells and how genetic interaction networks are rewired across lineage and oncogenic lesion. Discoveries from this project will guide combinatorial therapies targeting novel synthetic lethalities and enable researchers worldwide to gain deeper insight into the complexity of the mammalian cell.